Training in Molecular Toxicology

This is a renewal of the training grant “Training in Molecular Toxicology” at UCLA that was last renewed in
2014. Our highly interdisciplinary program, uniquely focused on mechanisms of toxicity, gathers faculty from 11
departments in 4 different schools at UCLA behind the common goal of mentoring pre-doctoral and
postdoctoral trainees in the investigation of the mechanisms of action of toxicological agents and the
evaluation of their impacts on health and the environment. Our specific programmatic objectives are to (1)
Foster novel and scientifically cutting-edge interdisciplinary research in mechanistic toxicology; (2) Provide
didactic and hands-on research experience to create a comprehensive training in toxicology from molecules
and large molecular datasets to pathology and disease; (3) Use laboratory research to model positive
mentoring and teaching skills for trainees' future careers; (4) Develop our trainees' soft skills, including writing
skills for publications and grants, speaking skills for presentations, and networking skills; (5) Create a
welcoming, engaging, respectful training environment that is diverse in all measures, where each trainee feels
that they have a voice and are a valued contributor within a larger community. We request four predoctoral
slots and two postdoctoral slots. This number of trainee positions requested is justified by the substantial
NIEHS and non-NIEHS funding of our faculty (averaging $498,701 total annual direct costs per person), our
success in recruiting excellent predoctoral and postdoctoral trainees, our successful endeavors in URM trainee
recruitment, the excellent publication record of the recent trainees in high impact journals (including Nature
Comm., PNAS, PLoS Genetics, Cell Reports, Environmental Health Perspectives, Cancer Research, J. Biol.
Chem., J. Neuroscience, Genetics, Plant Cell, and J. Immunology), and the successful transition of our past
trainees into important positions in academia, government or industry. The UCLA Molecular Toxicology
program is well supported by UCLA, which has committed considerable resources to it, including the
recruitment of a new faculty for a state-funded tenure-track position in the area of the molecular toxicology of
disease. Molecular toxicology is also one of the hiring priorities for another future recruitment. The faculty have
seven major foci of research interests: neurotoxicology (particularly the role of pesticides in the etiology of
Parkinson's disease), air pollution (the toxic effects of secondhand cigarette smoke, wild-fire smoke, and of
fossil fuels and their combustion products), toxico-epigenetics (effects of endocrine disruptors and other
toxicants), nanotoxicology, big data/computational toxicology, gene-environment interactions and susceptibility,
and alternative model organisms and predictive toxicology. These research foci are highly relevant to
environmental challenges confronting California and the nation. Renewal of the training grant will further
stimulate molecular toxicological research and training at UCLA, should encourage more students and
postdocs to pursue research in toxicology, and will signal the increasing importance of toxicology at UCLA.

Public health relevance
PROJECT NARRATIVE The predoctoral and postdoctoral trainees of the training grant in “Molecular Toxicology” at UCLA will acquire expertise in how to perform research on the mechanisms whereby environmental pollutants cause disease. Great strides in the identification, appraisal, and amelioration of the toxicological risks of environmental pollutants are likely to emanate from such studies.